Cellular Imaging Facility Core

The Cellular Imaging Facility Core provides members of the Southwest Environmental Health Sciences Center
(SWEHSC) with cutting-edge and routine capabilities for the visualization, quantitation, and interpretation of
structural and in situ molecular alterations in tissues and cells following exposure to toxicants with the goal of
advancing current knowledge in environmental health research. Importantly, the Core supports the mission and
vision of the SWEHSC by facilitating the research efforts of center investigators and by ensuring the accessibility
of microscopy and specialized imaging techniques, particularly for investigators, staff, and students lacking
extensive microscopy experience. To support SWEHSC investigators, the Cellular Imaging Facility Core
provides personalized training and technical assistance to investigators and their staff in the use of the affiliated
facilities and instrumentation. Likewise, the Facility Core ensures that the Center investigators have “state-of-the
art” equipment and techniques, and are provided with the relevant scientific expertise and training to obtain and
interpret their data. The Facility Core is engaged in all aspects of a study and assists users with experimental
design, specific procedures, instrument optimization and troubleshooting, data analysis, and the final
interpretation of results, including assistance in the preparation of portions of manuscripts and/or grant
applications. Finally, the Cellular Imaging Facility Core offers innovative imaging techniques that can be used in
combination or to confirm the results of molecular biology, biochemical, or analytical chemistry analyses, which
enables the generation of data that cannot otherwise be gained and that are necessary to elucidate toxicant sites
and modes of action.